Mobility Life: Monitoring Mobility in Daily Lives of People with Neurological Disease

Project Summary Falls are the leading cause of injuries, hospital visits, nursing home admissions, and reduced quality of life for people with neurological disorders. Although there is consensus that impaired mobility is the basis for most falls, it is very diﬃcult to evaluate these complex abilities outside a laboratory setting. Brief clinical examinations do not accurately reﬂect daily, functional mobility in real life environments. Patients at risk of falls would beneﬁt from a system they can easily use to measure their daily mobility, assess mobility ﬂuctuations throughout the day, evaluate their risk of falling, and measure eﬀects of interventions aimed at improving their functional mobility and reducing their falls. No commercial technology yet exists to continuously monitor ﬂuctuations in mobility or quantify fall risk in natural environments during normal activities. We developed and validated an unobtrusive system, called Mobility Life, to objectively characterize gait and turning during spontaneous activities with wearable inertial sensors. During this Phase II, we will develop an instrumented ankle wrap for continuous monitoring of gait, develop a user interface to support clinical research, develop reports that show indications of fall risk for clinical practice, and thoroughly verify and validate our technology. We will also determine which metrics are most indicative of fall risk and determine normative values for non-fallers in the same age range as the expected patient populations. Our speciﬁc aims are: AIM I. Technology Development: Prepare Mobility Life for clinical practice. · Milestone 1: Develop an instrumented elastic ankle bandage (SmartSox) for continuous gait monitoring. · Milestone 2: Develop useful clinical reports to convey patients' daily mobility impairments, ﬂuctuations, and fall risk. · Milestone 3: Complete the system veriﬁcation and validation in preparation for FDA 510(k) clearance to market. Aim II. Clinical Research: Demonstrate the clinical utility of Mobility Life to monitor quality of functional mobility and fall risk in neurological patients. · Milestone 4: Determine which daily life mobility impairments best predict fall risk in patients with PD or MS. · Milestone 5: Develop reference values for integrity of functional mobility in healthy age-matched subjects.

Public health relevance
Project Narrative The objective of this Phase II project is to develop and commercialize a wearable inertial sensors system, called Mobility Life, for continuous monitoring of mobility. At the completion of the proposed work for this direct to Phase II grant, we will have the ﬁrst system that can continuously measure mobility, characterize turning and balance during gait across weeks of continuous monitoring of patients in and outside their home, and assess patients' fall risk. We will also have the ﬁrst wirelessly synchronized ankle wrap instrumented with inertial sensors to monitor gait and foot movements. Mobility Life will be suitable for use in medical applications to assess mobility ﬂuctuations, response to medication, and disease progression in people with neurological disorders such as Parkinson's disease(PD) and multiple sclerosis (MS).